Admin-Core

The overarching goal of the Administrative Core (Core A) is to facilitate and coordinate activities and objectives
of the collaboratory including funding of pilot projects, pilot project support cores, engagement of stakeholders,
engagement of academic and industry partners, national outreach, education and training, and dissemination
and commercialization of collaboratory products. These activities are essential to the overall success of the
proposed Penn Artificial Intelligence and Technology (PennAITech) Collaboratory. Core A will be led by Dr.
Jason Moore (contact MPI) who has significant leadership experience across three different institutions including
founding and leading several research support cores, founding and leading several graduate education
programs, and founding and leading three different campus-wide research institutes including his current role as
Director of the Penn Institute for Biomedical Informatics (IBI) which has a strong focus on artificial intelligence
and machine learning. Further, he has departmental leadership experience as the founding Director of the
Division of Informatics at Penn Medicine and institutional leadership experience as the founding Senior Associate
Dean for Informatics at Penn Medicine. As such, he is in a strong position to lead this core and take advantage
of a strong administrative team to assist him in executing the specific aims and coordination plan outlined below.
Dr. Moore will be assisted by Dr. Jason Karlawish (MPI) who serves as Co-Director of the Penn Memory Center.
Dr. Karlawish is a Professor of Medicine, Medical Ethics and Health Policy, and Neurology at the University of
Pennsylvania Perelman School of Medicine. He will also be assisted by Dr. George Demiris (MPI) who is a
Fellow of the American College of Medical Informatics (ACMI) and a Penn Integrates Knowledge (PIK) University
Professor of Nursing and Informatics at the University of Pennsylvania School or Nursing and the Perelman
School of Medicine.

Public health relevance
Successful aging in the home can greatly improve quality of life, improve health outcomes, and reduce burden on the healthcare system. The goal of this project is to establish a national collaboratory for the development, evaluation, and implementation of artificial intelligence software and new technologies to facilitate health aging in the home. The administrative core will facilitate scheduling, logistics, event planning, communication, computer programming, and web design.